Parkinson Disease Clinical Subtypes: Validation, Clinical Utility, and Biological Correlates

ABSTRACT
Parkinson disease (PD) is a progressive neurodegenerative disease characterized by motor, cognitive, and
psychiatric manifestations resulting from abnormal protein deposition and neurotransmitter deficits. The
variability in clinical presentation and progression likely reflects different PD subtypes, which may be associated
with the underlying variability in brain pathology. Although current treatments provide dramatic motor benefit in
PD, they fail to alleviate some aspects of gait impairment and non-motor symptoms and may exacerbate
cognitive and psychiatric features. To develop more personalized interventions to treat, forestall or prevent these
features, more information regarding PD subtypes is necessary for patient selection and stratification, predicting
progression, and evaluation of novel treatments. Therefore, we propose to examine the clinical and prognostic
utility of PD subtypes and their stability through longitudinal behavioral assessments; determine the biological
markers of PD subtypes from multimodal neuroimaging, CSF, and brain autopsy data; and translate the PD
subtypes to a clinical setting.

Public health relevance
PROJECT NARRATIVE Individuals with Parkinson disease (PD) often develop a combination of motor, cognitive, and psychiatric problems that adds substantial morbidity, mortality and economic burden to patients, families and society. The variability in clinical manifestations across individuals reflects different PD subtypes. This study will compare clinical progression and biological measures across subtypes, thus yielding methods for patient stratification, targets for treatment intervention, and the ability to predict PD progression.